Academy of Molecular Imaging 2004 Annual Meeting

The objectives and specific aims of this application are to educate graduate students, postdoctoral fellows and residents in molecular imaging. The annual meeting of the Academy of Molecular Imaging (AMI) brings together a unique group of physicians, scientist and students from academic institutions, pharmaceutical companies, hospitals and industry to create a forum for sharing the latest research and developments in all areas of molecular imaging. The annual conference features parallel tracks specific to each council of the AMI, the Institute for Molecular Imaging, the basic science and instrumentation development council; Society of Non-lnvasive Imaging in Drug Development, the molecular therapeutics councils; the Institute for Clinical PET, the clinical council, and; the Institute for Molecular Technologies, the industry council. We are fortunate to have confirmed a number of esteemed and engaging speakers, including keynote speakers Dr. Andrew von Eschenbach, Dr. Nora Volkow and Dr. Mark Ellisman. Some of the topics that will be discussed are: PET/CT applications; Assay Development; Multi-modality Imaging; New targets for Imaging; Instrumentation/Image Analysis; Drug Development in Oncology; NIH Molecular Libraries and Imaging Roadmap plus selected abstracts of the latest basic science, drug development and clinical findings. The meeting will be held from March 27 - 31, 2004 at the Gaylord Palms in Orlando, Florida.